CHEMOTHERAPY AND CHEMOTHERAPY WITH ALPHA INTERFERON IN MALIGNANT MELANOMA

To compare the response rates and survival of patients with metastatic malignant melanoma treated with multidrug chemotherapy alone and in combination with alpha interferon.